Kappa opioid and oxytocin interactions in social buffering and separation

Project abstract Social connectedness is crucially important to human health, and is increasingly
recognized as such, especially in these days of “social distancing”. While strong social relationships may
confer a survivorship advantage with large effect sizes similar to those for health behaviors like diet and
exercise1, disruption and loss of social relationships carry significant health risks and mortality, including
increased risk of mental illness, cardiovascular disease, stroke, etc.2–4. However, neurobiological mechanisms
for positive and negative aspects of social connectedness have been under-studied. The κ opioid system,
which is systematically activated during stress (including social stress), and oxytocin (OT), a hormone strongly
implicated in social connectedness (and in particular, their interactions), have not been fully explored in the
contexts of positive and negative effects on social connectedness.
In the current proposal, we will investigate biological mechanisms for positive and negative mechanisms of
social connectedness (social buffering and separation), particularly in the κ opioid and oxytocin (OT) systems.
By using a unique non-human primate model, the titi monkey (Plecturocebus cupreus), we will be able to
address mechanism and causality in a way difficult or impossible to do in humans. Titi monkeys are a socially
monogamous New World primate. They exhibit all the signs of adult pair-bonding both in the wild5–7 and in the
laboratory8–10, including a preference for the familiar partner11; distress upon separation from the partner
specifically12; and the ability of the partner to buffer the stress response12; they are thus the perfect primate
model in which to study the neurobiology of pair bonding in all its aspects, including social buffering and
separation13. This socially monogamous mating system allows us to study adult attachment in adult males as
well as females, which is not possible in other common laboratory models like rats, mice, and rhesus monkeys.
We have shown the separation response is modulated by opioids and that the OT system is also responsive to
separation.
We will use C11 PET imaging and pharmacological treatments during social buffering, short term
separation, and longer-term separation to test the hypothesis that the κ opioid receptor and OT interact such
that activation of the κ system results in inhibition of OT in the nucleus accumbens during social separation and
loss; chronically, social separation and loss will result in down-regulation of κ opioid receptors and stimulation
of OT in the hypothalamus; while inhibition of κ receptors, and downstream effects on OT, are implicated in the
positive, anti-stress components of social bonds. Ultimately, this project will improve our understanding of the
neurobiological basis of social connectedness in both its positive and negative aspects, providing for
mechanistic connections to human health.

Public health relevance
Project Narrative Social relationships are crucially important to human health; however, we do not fully understand what in our brains drives us to form relationships, to feel loss when the relationships end, or to allow our partners to reduce our stress levels (also called “social buffering”). In this project, we will study titi monkeys, which form adult pair bonds, using imaging and drug manipulations to examine the neurobiology of social buffering and separation.